Durable Zwitterionic Coatings: Dramatic Reduction of Implant-Induced Inflammation and Fibrosis

Project Summary/Abstract: Polydimethylsiloxane (PDMS), also known as silastic, is commonly used for
medical implants. Despite advantages over earlier elastomers and plastics, PDMS surfaces elicit a significant
foreign body response (FBR). This response, triggered by adhesion of non-specific proteins, leads to a thick
fibrotic capsule post-implantation, impacting the functionality, safety, and longevity of various medical devices.
For neurostimulators such as cochlear implants (CIs), this fibrotic tissue increases the impedance of the nerve -
tissue interface and has other deleterious effects, e.g., reduced hearing quality in the case of CIs. Similarly, in
stents, catheters, and tubes, the FBR can permanently damage tissue, narrow passageways, and restrict flow
rates. A notable example is endotracheal (ET) tubes, which commonly induce subglottic stenosis in long-term
intubated patients, leading to life-long complications. Moreover, PDMS-based implanted biomaterials are prone
to bacterial biofilm formation, presenting a significant risk for infections. Hospital-acquired infections associated
with implanted devices incur ~30 billion dollars annually in healthcare costs in the U.S. alone. To address these
challenges, surface modifications to enhance the biocompatibility of PDMS have been a significant focus of
research. While impressive antifouling properties have been realized in a variety of coatings—and particularly
those based on zwitterionic polymers—these coatings have yet to be incorporated in commercial biomedical
devices due to weak grafting to the PDMS surface, inadequate mechanical durability, and complex processing
steps that aren’t easily transferable to existing manufacturing processes. Our company, ZwiCoat Materials
Innovations (ZCMI), has developed the first ever ultra-low-fouling thin film coating that forms a permanent,
covalent bond with PDMS surfaces in a simple one-step process. This patented technology combines several
properties crucial for commercial viability: strong covalent bonding to PDMS, high lubricity, mechanical durability,
and exceptional antifouling capabilities—all achieved through a straightforward, single-step photoinitiated
reaction that can be integrated with existing manufacturing protocols. This SBIR project aims to establish the
technical merit and feasibility of applying our innovative coating to two existing medical implants, CI electrode
arrays and ET tubes—both of which would benefit from greatly reduced fibrosis and are representative of large
classes of biomedical devices. The project aims to develop efficient coating technologies, validate coating
durability, while confirming their robust antifouling properties on these devices. Phase I success is expected to
enable industry partnerships and pave the way for regulatory approval. Concurrently, targeted interviews with
hospitals, physicians, patients, and industry leaders will be conducted to inform and refine subsequent Phase II
work as well as our commercialization strategy. This approach will position ZCMI to revolutionize the current
paradigm wherein fibrosis and moderate infection rates are viewed as inevitable consequences of implanted
medical devices, thereby establishing a new standard for patient safety and device efficacy.

Public health relevance
Project Narrative: ZCMI is pioneering the application of zwitterionic thin-film coatings to existing medical implants—e.g., cochlear implants and endotracheal tubes—to greatly reduce scarring and infection rates that are common complications in these devices. Our company’s patented one-step process produces a mechanically-robust, ultra-low-fouling coating that permanently bonds to biomaterials. This SBIR project targets the development of scalable coating methods, rigorous testing under practical operating conditions, and comprehensive industry consultations in order to set the stage for a transformative commercial impact on the medical implant industry.